Neural mechanisms of maturing out of problem alcohol use

ABSTRACT
There is a normative decrease in problem alcohol use that naturally occurs in the mid-20s after binge and
heavy drinking peak, a process called “maturing out”. While most young adults mature out of problem use, a
subset persist or escalate in their drinking; these individuals are at risk for lifetime struggles with alcohol use
disorders. What differentiates those who mature out of problem drinking versus those who do not is not fully
understood. Developmental changes in the brain are hypothesized to play a central role in the alcohol
consumption shifts that define the maturing out period, as neural maturation is not fully complete until the mid-
20s. Furthermore, young adulthood is a critical neurodevelopmental period when subcortical emotion and
reward-related and cortical cognitive control regions mature, concomitant with improvements in executive
control and declines in impulsivity and sensation-seeking. Despite the presumed effect that neural maturation
has on decreases in risky behavior (like heavy alcohol use), no study has directly tested associations between
neurobiological processes and trajectories of alcohol use in young adulthood.
For this study, we will recruit 400 individuals between the ages of 21 and 25 (50% female) who report at least
one binge drinking episode a month for the past 3 months to undergo high-resolution structural magnetic
resonance and functional imaging scans (cognitive control, emotion regulation, alcohol cue reactivity, and
resting state) at baseline. Detailed neuropsychological and psychosocial measurements will also be collected.
Follow-up assessments will consist of 1) self-report alcohol use, measured online every 3 months post-scan to
examine trajectories of use, and 2) neuropsychological and psychosocial measurements, collected online
every year post-scan. Participants will be recruited during Years 1–3. Follow-up assessments will be collected
until the end of the study, maximizing the data collection period and allowing for a large follow-up age range
(25–29 years). We will model alcohol use trajectories across time, using baseline imaging data as a marker to
differentiate or predict participants who persist or desist in use. This design will allow us to 1) determine the
extent to which neural and behavioral mechanisms of cognitive control, emotion regulation, and reward/cue
reactivity predict drinking trajectories, and 2) examine the effect of problem drinking on these processes. As
sex differences in cognitive control, emotion, and reward development likely introduce variability in alcohol use,
3) we will also characterize sex differences predictive of alcohol use trajectories. As an exploratory analysis,
we will investigate neurobiological predictors of maturing out using multimodal (structure, resting state, task)
MRI data analysis.

Public health relevance
PROJECT NARRATIVE There is a normative decrease in problem alcohol use that occurs in the mid-20s, after binge and heavy drinking peak, a process that is called “maturing out”; while most young adults mature out of problem use, a subset of individuals persist or escalate their drinking. The proposed study will use functional magnetic resonance imaging to identify structural and task activation patterns predictive of alcohol desistence and persistence during the maturing out period in order to provide important information about those who are at the greatest risk. Such mechanistic knowledge is critical for downstream research, such as the development of targeted interventions to mitigate the emergence of alcohol use disorders, and the development of efficacious treatment tailored specifically for those who do not mature out of problem alcohol use.